Defining a stromal niche for type 2-like lung regulatory T cells

Project Summary
Lung diseases such as acute lung injuries (ALI) and acute respiratory distress syndrome (ARDS) are leading
causes of morbidity and mortality worldwide. Regulatory T cells (Tregs) are traditionally thought of as critical
negative regulators of systemic immune responses; however, their local roles in tissues such as the lung are
being increasingly appreciated, where they can promote lung epithelial regeneration in both ALI and ARDS.
Subsets of tissue-resident Tregs (tTregs) are found to express transcription factors T-bet, Gata3, RORt, and
Bcl6, and have enhanced suppression towards their Th1, Th2, Th3/17, and Tfh immune ‘flavors,’ respectively.
Although tTreg function are beginning to be understood, how lung tTregs are regulated, positioned, and
maintained within their respective tissue niches remains unknown. Mesenchymal stromal cells (MSCs) are
immune regulators and have been highlighted to play a role in tTreg biology. Production of IL-33 by a subset of
MSCs promotes the expansion and maintenance of visceral adipose tissue tTregs and human MSCs can induce
Tregs from conventional CD4+ T cells in vitro. Our group identified a stromal cell niche within the lung where
adventitial fibroblasts (AFs), an MSC subset, regulate type 2 effector lymphocytes (e.g. ILC2s and Th2 cells), in
part via the secretion of IL-33 and thymic stromal lymphopoietin (TSLP). Using 3D thick section imaging, I have
shown that lung type 2-like tTregs (i.e. Gata3hi ST2+, KLRG1+) also localize to this niche, indicating AFs may
regulate lung tTregs and their subsets. When co-cultured with lung AFs, lymphoid Tregs significantly increased
proliferation, survival, and expression of type 2-like Treg markers ST2 and KLRG1 in a contact-dependent
manner. Additionally, AFs preferentially support ST2hi Tregs, as evidenced by higher proliferation, survivability,
and ST2 and KLRG1 expression. Using CellphoneDB V2.0, I identified extracellular matrix (ECM)–integrin
ligand–receptor pairings, such as ICAM, VCAM, and CD49d, that may mediate interactions between AFs and
Tregs. Upon blocking all three in a co-culture system, I found a significant decrease in Treg proliferation and ST2
and KLRG1 expression. I hypothesize that AFs regulate the maintenance and differentiation of lung Treg subsets,
preferentially supporting type 2-like lung Tregs, which play critical roles in post-injury lung repair. This proposal
will define the topography of type 2 lung tTregs and their role in naïve and inflammatory settings (Aim 1) and
determine the role of adventitial fibroblasts in the regulation of lung Treg subsets (Aim 2). This work utilizes
murine models of inflammation, as well as genetic ablations to dissect the local type 2 tTreg response in the lung.
High-dimensional flow cytometry, advanced imaging, and lung function measurements will be used to quantify
impacts on immune cells and functional lung recovery. Completion of these aims will elucidate the role of AFs in
the function and regulation of lung type 2 tTregs, providing novel mechanistic insight into the role MSCs play in
regulating immune subsets. Completion of this study provides a foundation for the development of precision
therapeutics to selectively regulate lung tissue Tregs subsets to impact the outcome of diverse lung diseases.

Public health relevance
Project Narrative Acute lung injuries (ALI) are a leading cause of morbidity and mortality worldwide. After injury, the lung undergoes reparative processes and regulatory T cells (Tregs) are lymphocytes that play critical roles in lung repair, yet there is little mechanistic understanding of how Tregs are regulated and maintained within the lung. This work investigates the role of lung Tregs and how they are locally regulated and maintained, which would inform the design of new precision therapeutics to ameliorate ALI in humans.